Fetal ethanol-induced behavioral deficits: Mechanisms, diagnoses and intervention

PROJECT SUMMARY - OVERALL
NMARC is a NIAAA-designated Alcohol Research P50 Center at the UNM Health Sciences Center. The center
is comprised of teams of preclinical and clinical scientists with a history of collaborative research interactions
whose expertise and contributions have synergized the center’s research environment and is facilitating progress
towards the achievement of NMARC’s three strategic objectives. These strategic objectives are to: 1) Advance
our understanding of how prenatal alcohol exposure affects basic neurobiological mechanisms resulting in
functional brain damage which can lead to life-long adverse neurobehavioral consequences. 2) Develop more
effective approaches for the diagnosis of individuals with FASD through the establishment of more sensitive and
clinically reliable biochemical, physiological and neurobehavioral biomarkers of alcohol exposure that are
detectible early in life, are prognostic of functional brain damage, and could predict long-lasting neurobehavioral
consequences in patients with FASD. 3) Develop interventions that are more effective for prenatal alcohol-
related behavioral deficits. Better interventions may ultimately require combinations of neurobehavioral,
educational and/or pharmacotherapeutic approaches to ameliorate the often subtle, but long-lasting impact of
prenatal alcohol-induced behavioral problems. NMARC’s prevailing philosophy is that a research center
organized to maximize the coordination, communication and synergistic integration across multiple lines of
preclinical and clinical investigation in these three strategic objective areas provides the best long-term prospect
of achieving significant progress towards the dual clinical goals of better diagnosis and more effective
interventions for patients with FASD. NMARC’s specific aims as an integrated whole during the P50 Phase II
will continue to be to: 1) Accelerate progress on each on NMARC’s three strategic objectives. 2) Catalyze the
expansion of NMARC’s research capacity and capabilities. 3) Enhance our capability to disseminate knowledge
about FASD through seminars, symposia and community outreach activities. 4) Increase the number of
undergraduate and graduate students, fellows and residents training in the FASD research field. This P50
competing renewal contains four research components, each consisting of teams of investigators whose projects
address one or more of NMARC’s three strategic objectives. Two core components support the center’s
research program: 1) A Pilot Project Core with two two-year projects involving faculty investigators new to the
FASD research field. 2) An Administrative Core that provides scientific and administrative leadership for the
entire NMARC program, along with administrative support and budgetary oversight of all NMARC-related
activities. The Administrative Core is also responsible for ensuring progress toward achieving the specific aims
of the center as a whole. Assessment of NMARC’s progress towards the achievement of these aims and the
strategic objectives is the responsibility of the Executive and Steering Committees working in conjunction with
our external Program Advisory Committee comprised of seven internationally renowned FASD scientists.

Public health relevance
PROJECT NARRATIVE - OVERALL Alcohol consumption during pregnancy increases the risk of causing functional brain damage in the fetus that can lead to adverse, life-long neurobehavioral consequences. Except in more severe cases, many children affected by fetal alcohol exposure are difficult to identify, particularly early in life when interventional approaches could have the greatest positive impact. The New Mexico Alcohol Research Center’s objectives are to advance our understanding of how alcohol causes functional brain damage and use this information to help develop better procedures for the diagnosis and treatment of prenatal alcohol effects earlier in life.